Enhancing Effectiveness of a Dissonance-Based Obesity Prevention Program

ABSTRACT
Prevention is key for combating obesity, but few programs have prevented future increases in BMI and onset
of overweight/obesity, particularly during late adolescence when youth often assume responsibility for dietary
intake and exercise choices. One exception is a brief 6-hr dissonance-based program (Project Health) wherein
participants make small lasting incremental lifestyle changes to dietary intake and exercise to reach energy
balance, and discuss costs of obesity, an unhealthy diet, and sedentary behavior, and benefits of leanness, a
healthy diet, and exercise, which prompts them to align their attitudes with their publically displayed behavior.
These activities promote internalization of health goals and executive control over lifestyle behaviors. Late
adolescents randomized to Project Health showed less increases in BMI and a 41% and 43% reduction in
overweight/obesity onset over 2-yr follow-up compared to a version of the program lacking dissonance-
induction activities and an obesity education condition. Project Health appears to be the first program to
produce these key obesity prevention effects relative to an alternative intervention, but it is critical to increase
effects. A dissonance-based prevention program was more effective when implemented in single- versus
mixed-sex groups, theoretically because it promoted greater participation in dissonance-inducing discussions.
Aim 1a is to test whether the weight gain prevention effects will be larger when Project Health is implemented
in single-sex groups; we will randomize 450 17-20 year olds to complete Project Health in female, male, or
mixed-sex groups, assessing outcomes at pretest, posttest, and 6, 12, 24, and 36-month follow-ups. Aim 1b is
to test whether greater participation in dissonance-inducing discussions and group cohesion mediate the effect
of condition on any superior weight gain prevention effects. Adolescents who show greater fMRI-assessed
reward and attention region responsivity to food images exhibit elevated future weight gain, implying that
reducing this responsivity may reduce future weight gain. In a pilot trial, late adolescents who completed go/no-
go, stop-signal, and respond-signal computer training in which they repeatedly inhibit responses to high-calorie
foods and respond to low-calorie foods, and dot-probe and visual-search computer tasks that train attention
away from high-calorie foods and to low-calorie foods, showed a greater reduction in reward and attention
region responsivity to, palatability rating of, and willingness to pay for, high-calorie foods, suggesting reduced
valuation and attentional bias, as well as greater fat loss over 1-yr follow-up versus controls who completed the
training with non-food images. Aim 2a is to test whether adding food response and attention training to Project
Health will produce larger weight gain prevention effects. Participants in the 3 conditions will be randomized to
complete response and attention training for 25-mins after each of the 6-sessions with either food or non-food
images. Aim 2b is to test whether reduced palatability ratings of, willingness to pay, and attentional bias for
high-calorie foods mediate the effect of training condition on any superior weight gain prevention effects.

Public health relevance
PROJECT NARRATIVE This project seeks to improve the effectiveness of a novel dissonance-based obesity prevention program that has reduced future BMI gain and overweight/obesity onset by (a) experimentally testing whether implementing it in single- versus mixed-sex groups, which should increase dissonance-induction that contributes to weight gain prevention effects, and (b) experimentally testing whether adding food response and attention training, which theoretically reduces valuation of and attention for high-calorie foods, increases weight gain prevention effects. This randomized trial would be the first to experimentally manipulate these two factors in an effort to produce superior weight gain prevention effects. A brief effective obesity prevention program that can be easily, inexpensively, and broadly implemented to late adolescents at risk for excess weight gain, as has been the case with another dissonance-based prevention program, could markedly reduce the prevalence of obesity and associated morbidity and mortality.